Poly(glycerol carbonate) pressure sensitive adhesives for the in vivo closure of alveolar pleural fistulae

Project Summary/Abstract
This fellowship will support the interdisciplinary research and training of Ms. Danielle Fitzgerald under the
co-sponsorship of Dr. Mark Grinstaff of Boston University and Dr. Yolonda Colson of the Massachusetts
General Hospital/Harvard Medical School’s. The training aspects of the proposal include four pillars:
interdisciplinary research, multi-disciplinary mentoring, academic engineer-scientist training, and
professional development. This personalized training plan provides a unique opportunity for learning in the
biomaterials area with critical clinical input, and specifically addresses her career goal of becoming a professor
at a top-tier university. Drs. Grinstaff and Colson will continue to meet regularly with the fellow as part of her
three-year plan and will provide the necessary resources (space, equipment, supplies, training, etc.) for her
success.
On the research front, her proposal describes new biodegradable, biocompatible pressure sensitive
adhesives (PSAs), with tunable adhesion strength, for in vivo use. This innovative technology overcomes the
limitation of current PSAs, which are only used topically. Together with Drs. Colson and Grinstaff, the repair of
alveolar pleural fistulae was identified as a significant and problematic clinical procedure in thoracic surgery
associated with increases in health care costs and high mortality rates. Today, closure of such leaks is
challenging due to limited space and to an inherent pressure gradient across the fistula. Specifically, Ms.
Fitzgerald is evaluating novel poly(1,2-glycerol carbonate)s (PGCs) which functionally mimic conventional
polyacrylate PSAs but possess biodegradable carbonate linkages and degrade into benign products – e.g.,
glycerol, CO2. These first-of-their-kind polymers provide an opportunity to create a new class of PSAs and shift
the paradigm around our ability to control and manage intrathoracic wounds. The proposed experiments will
test the hypotheses that these PGC based pressure sensitive adhesives will: 1) exhibit compositionally
dependent adhesive strength which positively correlates with greater molecular weight, longer alkyl
chains, and stereoregularity; 2) display peel strengths which can be tuned over a wide range from
Post-it® note to Duct® Tape like performance; and, 3) enable securing a collagen buttress to a surgical
stapler or an electrospun polylactide mesh patch for sealing lung injuries. Her specific aims are: Aim 1.
Synthesize and characterize a series of PGC-based pressure sensitive adhesives; Aim 2. Evaluate the
compatibility of the PGC-adhesive collagen and PLA patch in vitro and in vivo; and, Aim 3. Evaluate the
performance of the PGC-adhesive collagen and PLA patch in porcine models. Importantly, preliminary data
support these hypotheses, and well-characterized materials and rigorous experimental designs are established
in this proposal with essential cross-disciplinary collaborations and expertise from Ms. Fitzgerald’s Sponsors,
co-advisors/co-mentors, and dissertation committee members included.

Public health relevance
Project Narrative A pleural fistula, or opening between the pleural cavity and lung airway, originates from injury or locally invasive cancer. Closure of alveolar pleural fistulae remains a serious surgical challenge with high morbidity or mortality, and it would benefit from new sealing techniques and adhesives. The specific and guided clinical focus of this multi-disciplinary pre-doctoral training program in biomaterials is the evaluation of novel biodegradable, biocompatible pressure sensitive adhesives for in vivo closure of pleural fistulae.